DAPSONE AND ATOVAQUONE STUDY FOR PCP IN HIV INFECTED PATIENTS

ACTG 277 CPCRA 034 A randomized, comparitive study of daily dapsone and daily atovaquone for prophylaxis against PCP in HIV-infected patients who are intolerant of trimethoprim and/or sulfonamides.